The Role of AP1 Family Members in Hormone Gene Expression

Not Applicable, per PA 18-906 an abstract is not required for this Administrative Supplement

Public health relevance
Not Applicable, per PA 18-906 a narrative is not required for this Administrative Supplement